Developmental Funds

DEVELOPMENTAL FUNDS
ABSTRACT
Huntsman Cancer Institute (HCI) utilizes Developmental Funds to support critical initiatives identified via
strategic planning and evaluation, with the goal to build capacity at our Cancer Center and to further our
mission. In the coming award period, investments will be focused in four areas:
Faculty Recruitment: During the current review period, HCI doubled its research space via construction of the
Primary Children's and Families Cancer Research Center at HCI (Research South, 225,000 ft2, $119M,
opened June 2017). With the benefit of these new facilities and HCI’s programmatic resources, we aim to
increase our Cancer Center membership through recruitment of six faculty per year over the next five years
(2019-23). HCI requests Cancer Center Support Grant (CCSG) funds for partial support of selected HCI
strategic recruitments.
Research Staff Investigators: HCI Staff investigators are supported through CCSG Developmental Funds to
enable the advancement of key strategic objectives of the Center. Lisa Cannon-Albright, PhD, is a highly
experienced user of our unique biomedical research resource, the Utah Population Database (UPDB). She
educates and collaborates with faculty interested in using UPDB to identify families with undue burden of
disease for studies. Jennifer Doherty, MS, PhD is an expert in team science, who works to enhance
collaborative interactions at the Cancer Center, mentoring both junior researchers and established researchers
in transdisciplinary approaches. She also builds cross-specialty teams that incorporate molecular
epidemiologic research methodologies or integrate epidemiology with laboratory and clinical efforts.
Developing Shared Resource: To meet the evolving research needs of our membership, HCI has created an
emerging shared resource, the Preclinical Research Resource (PRR), focused on the development and
utilization of preclinical models of disease, including patient-derived xenograft models, genetically engineered
mouse models, and organoid models. PRR supports HCI’s mission to advance the understanding of cancer
mechanisms and develop novel cancer interventions. HCI requests CCSG funds to provide partial support.
Pilot Research Funding: To support promising pilot research, HCI provides Research Programs with
institutional, non-CCSG, funding. Funds are lodged in the hands of Research Program Leaders, to directly
empower them to reach their strategic goals and to advance collaborative, transdisciplinary research
approaches. $200K/year/program is awarded to each of HCI’s four Programs. HCI also supports its Disease
Centers with funding for preliminary studies. In total, HCI invests ~$2.3M/year to support pilot research. In
addition, funds have been dedicated to programmatic investigator-initiated trials ($700K) since 2017.